Project 3: Impact of tumor genetics on PDAC immunobiology and responses to macrophage-targeted immunotherapy

ABSTRACT (Project 3)
Pancreatic ductal adenocarcinoma (PDAC), an aggressive malignancy that is poorly responsive to treatment,
is characterized by a prominent infiltration of immune cells. In particular, macrophages are abundant within the
tumor microenvironment (TME) in PDAC and contribute to disease progression and treatment resistance.
However, the factors affecting the recruitment and distribution of immune cells, including macrophages, in
PDAC remain largely unknown. Recently, our collaborators in Project 1 found that tumors differing in their
Trp53 status exhibited different immune profiles. Our collaborators further observed that the cell type of origin
(acinar or ductal) influenced the tumor molecular subtype (classical or basal-like), which is also known to be
shaped by the immune composition of the tumor. We postulate that somatic alterations in cancer cells, the cell
type of origin, and tumor molecular subtype influence the immune landscape within the TME and throughout
the host during PDAC progression. To test this hypothesis, we will determine immune cell frequency,
distribution, and function in the TME and throughout the host using high-dimensional analytical tools (CODEX
and CyTOF) on genetically engineered mouse models (GEMMs) of PDAC that vary in their driver mutations
and cell type of origin (developed by Project 1). Additionally, we will use molecular methods to identify
immunomodulatory factors regulating immune cell recruitment in the context of different genetic mutations and
cell type of origin, and we will use genetic, pharmacological, and neutralizing antibody-based approaches to
confirm the functional effects of these factors in driving PDAC progression. Importantly, we will validate
findings from these studies in human PDAC specimens and in cell lines derived from human pancreatic ductal
cells. Finally, we recently found that the pattern recognition receptor, Dectin-2, is expressed on tumor-
associated macrophages (TAMs) in an aggressive, transplantable model of PDAC. Notably, administration of
natural Dectin-2 ligands induces sustained PDAC regression in a T-cell dependent manner by reprogramming
immunosuppressive TAMs into immunostimulatory antigen-presenting cells (APCs). We hypothesize that
PDAC can be effectively treated by reprogramming Dectin-2+ TAMs into immunostimulatory APCs. We will
treat autochthonous tumors arising in the GEMMs developed by Project 1 with Dectin-2 ligands to test this
hypothesis. Furthermore, to identify mechanisms by which Dectin-2 stimulation is therapeutically efficacious,
we will use CODEX and CyTOF to observe changes to the immune landscape occurring within the TME and
throughout the host upon treatment. Molecular approaches will be used to identify immunomodulatory factors
responsible for mediating therapeutic efficacy. Together, these studies will improve our understanding of how
the immune system is altered during PDAC development in the context of variation in genetic mutations, cell
type of origin, and molecular subtype, and in response to TAM reprogramming.

Public health relevance
PROJECT NARRATIVE (Project 3) Pancreatic ductal adenocarcinoma (PDAC) is characterized by an extensive infiltration of immune cells, and in particular, macrophages are abundant in the PDAC stroma, contributing to disease progression as well as resistance to treatment. However, the factors contributing to the immune landscape within the tumor microenvironment (TME) and throughout the host during PDAC development and progression are poorly understood. In this project, we seek to delineate the role of somatic cancer cell alterations, cell type of origin, and tumor molecular subtype in modulating the local and systemic immune profiles during PDAC development, and to investigate the mechanisms by which the immune landscape of the TME and the host are altered in response to therapy that reprograms immunosuppressive tumor-associated macrophages into immunostimulatory antigen-presenting cells.